IL-1-based immunotherapy in HNSCC

Background and Innovation: The standard of care for locally advanced (LA) head and neck squamous cell
carcinoma (HNSCC) is surgery followed by post-operative radiotherapy (RT) or chemoradiotherapy (CRT).
Unfortunately, patients have a high risk of locoregional failure after RT and up to 50% of patients will develop
recurrent disease and/or second primary tumors. Additionally, treatment options are limited for locally recurrent
and second primary tumors in a previously irradiated field. Therefore, there remains a significant need to
identify novel therapeutic strategies in order to improve clinical outcomes for LA-HNSCC patients. RT can
trigger anti-tumor immune responses and this may be exploited to improve the effectiveness of
immunotherapy. While RT/CRT in combination with immunotherapeutic agents is a promising strategy
conceptually, as more results are being reported from ongoing randomized phase 3 clinical trials, it is clear that
targeting checkpoint inhibitors (e.g. anti-programmed cell death protein 1 [PD1]) is safe, but does not improve
upon standard of care RT or CRT for LA disease. In this application we will test interleukin-1 (IL-1) ligands (IL-
1α and IL-1β) as an adjuvant to RT and CRT given the ability of IL-1 to target various aspects of anti-tumor
immunity (dendritic, natural killer and T cells,) and thus be effective in both immunogenic and poorly
immunogenic tumors. We hypothesize that IL-1 microparticle (IL-1MP)-based immunotherapy will trigger an
anti-tumor immune response and improve durable response rates to RT/CRT for HNSCCs.
Significance and Impact to Veterans Healthcare: Data from the Surveillance, Epidemiology and End
Results (SEER) cancer registry show that HNSCCs are almost twice as common (6%) in Veterans as in non-
Veterans (3%). Because of the high co-morbidity and overall poorer level of health seen in VA patients,
conventional chemotherapy is difficult and, in some cases, not appropriate for many VA patients. However,
immunotherapy-based strategies are highly suitable options for VA patients given the more favorable toxicity
profile compared to other chemotherapy strategies and the remarkable durable responses that can be
triggered.
Path to translation/implementation: Overall if our strategy of IL-1MPs in combination with RT/CRT is
successful, we will proceed with GLP toxicity studies and develop plans for GMP manufacturing for the IL-
1MPs. We believe that our combined strategy is a highly promising approach which may lower the risk of
locoregional recurrences and second primaries, and target distant tumors which will improve overall survival
outcomes in LA-HNSCC patients.

Public health relevance
Veterans have a disproportionately higher rate of head and neck squamous cell carcinoma (HNSCC) compared to the general population and the majority (~60%) of patients present with advanced locoregional disease (stage-III or IVA/B) at diagnosis. These patients have a high risk of developing secondary tumors even after local control is achieved. This application explores a novel combined radiotherapy-immunotherapeutic approach using the cytokine interleukin-1 (IL-1) with the potential to safely improve durable response rates and long-term survival for locally advanced HNSCC patients. If this application is successful, microparticle delivery of IL-1 in combination with radiotherapy would represent a highly novel combined radiotherapy- immunotherapeutic approach to improve survival outcomes for locally advanced HNSCC patients.